FEEDING STRATEGIES FOR LOW BIRTH WEIGHT INFANTS

The objectives of this study are to compare nutritional, metabolic, gastrointestinal and neurobehavioral responses of low birth weight infants to four orogastric tube-feeding strategies (early vs late introduction of enteral nutrition; continuous vs intermittent bolus feeding) and to describe the ontogeny of early oral feeding competence. (NRSU protocol)